Systemic Enzyme Delivery by a Brain Targeted SapC-DOPS Nanocarrier for Treatment of Neuronopathic Gaucher Disease

Summary
Gaucher disease (GD) is a common lysosomal storage disease, occurring at a rate of 1 in 500 in Ashkenazi
Jews and 1/60,000 in the general population. Defective acid β-glucosidase (GCase) in GD results in progressive
accumulation of glycolipid substrates in tissues leading to hepatosplenomegaly, weakened bone, impaired blood
clotting and neurological impairments. Despite many advances in GD therapy, treatments are only partially
effective for the more common visceral forms and are completely inadequate for a highly symptomatic and
frequently lethal subtype of the disease, neuronopathic GD (nGD), affecting the central nervous system (CNS).
Current enzyme replacement treatments (ERT) for nGD are limited by two major challenges: limited penetration
of the blood-brain barrier (BBB) and instability of GCase of existing ERT resulting in short half-lives in circulations
and organs. We have developed a novel Saposin C (SapC)-dioleoylphosphatidylserine (DOPS) nanocarrier that
can penetrate the BBB. When SapC-DOPS is combined with a novel stable enzyme, named fGCase, allows for
efficient transport into the brain with sustained bioactivity. Our intravenously delivered, long-acting SapC-DOPS-
fGCase retains kinetic stability in mouse plasma and cells, penetrates through the BBB into the CNS, and
displays prolonged activity leading to reduction of brain-accumulated glycolipid substrates. Preliminary results
suggest that interplay between SapC, phosphatidyl serine (PS), a receptor for SapC, and the lymphatic system
influences SapC-DOPS’s ability to transport the enzyme across the BBB and process in the brain. These
preliminary findings strongly suggest that the highly brain-stable SapC-DOPS-fGCase will maintain adequate
and sustainable activities to restore GCase function in GD brains. Based on these promising features of SapC-
DOPS and fGCase, our overall hypothesis is that SapC-DOPS-fGCase will reestablish GCase function in GD
brains and improve brain disease outcomes to advance enzyme treatment for nGD. In Aim 1, we will 1) determine
the pharmacokinetics and biodistribution of SapC-DOPS-fGCase, 2) evaluate the therapeutic impact in nGD
mouse models and human nGD iPSC-derived midbrain-like organoid model, and 3) investigate the underlying
mechanism(s) of this novel CNS-ERT approach in protecting neuronal cell functions. In Aim 2, we will define the
pathways involved in the transport of SapC-DOPS-fGCase across the BBB. Our focus will be to investigate the
interplay of cell surface PS and SapC-DOPS and the role of CNS-lymphatics for SapC-DOPS-fGCase
processing in the brain. Completing this preclinical study will provide proof of concept for SapC-DOPS-fGCase
to be a transformative ERT for human nGD. Additionally, we will gain a deeper understanding of PS-dependent,
CNS-targeting of SapC-DOPS through the CNS-lymphatic system.

Public health relevance
Project Narrative Gaucher disease is a common inherited lysosomal storage disease affecting 1 in 500 in Ashkenazi Jews and 1 in 60,000 in the general population. Available enzyme treatment is adequate for the form of the disease affecting organs outside the brain, but a highly lethal central nervous system subtype, unfortunately, lacks any effective therapy, primarily because current enzyme treatments do not cross the blood-brain barrier. We have developed a therapeutic approach utilizing a more stable enzyme linked to Saposin C-based nanovesicles that can cross through the blood-brain barrier, allowing delivery of the replacement enzyme into the brain and promising an effective treatment.